R21-UKY East Palestine Train Derailment Health Tracking Study

RESEARCH SUMMARY
On February 3, 2023, a freight train derailed and caught fire in the town of East Palestine, Ohio. Of the derailed
rail cars, ~20 of them were carrying hazardous materials, which were released into the air, soil, and water. Of
further concern, a controlled release/burning of the remaining toxic chemicals was performed prompting
officials to order an immediate mandatory evacuation of all residents. The evacuation order was lifted after the
U.S. Environmental Protection Agency released a statement that air quality was safe. However, residents
remain concerned about safety, while others have reported symptoms including headaches and difficulty
breathing, as well as odors in the home and in the community. At present, a systematic evaluation of the
experiences, exposures, and health symptoms (including stress outcomes), of the residents of East Palestine
and the surrounding area related to the train derailment disaster has not been conducted. Although multiple
entities – including federal and state agencies, and academic research teams – have been collecting
environmental and health data, community members are being bombarded with information and scientific data
that is not being communicated effectively. Moreover, the community does not have a structured mechanism to
provide their insight or recommendations for research. Thus, there is a clear need for a researcher network
and mechanisms to engage the community and facilitate dissemination of research findings. This proposal will
take the critical foundational steps toward launching longitudinal investigations of exposures and health
impacts and ensuring effective and targeted communication of results to residents in the East Palestine
community and surrounding populations. Given our longstanding community-engaged environmental health
science research studies in nearby communities, we are strategically poised to accomplish the following
specific aims. Aim 1: Examine experiences/concerns, health symptoms, psychosocial/traumatic stress,
emotional well-being, trust networks, and environmental health literacy of residents of East Palestine and the
surrounding area related to the train derailment disaster, as well as changes in these measures over time; and
Aim 2: Enhance communication among the scientific research community, federal, state, and local agencies,
and the East Palestine community. This time-sensitive and highly relevant study provides the first opportunity
for community members to identify their research priorities based on their experiences/concerns and includes a
health tracking study (via an online survey) to fully characterize and collect longitudinal measures of health
symptoms, stress, and well-being of East Palestine residents. To inform best practices for future disaster
response research, we will evaluate the impact of community-researcher interactions on building both trust and
environmental health literacy over time. The proposed study will also establish a researcher network to
enhance study methodology and inform research dissemination strategies.

Public health relevance
Narrative: A community-academic team will respond to the East Palestine derailment with a health tracking survey and strategies to engage the community in identifying their communication needs and environmental health research directions.